TSE climate chambers for precision-controlled temperature housing of rodents.

Project Summary/Abstract
The temperature of the ambient housing environment represents a major modifier of outcomes in many
studies. Maintenance of precise temperature and humidity control minimizes contributions to variation in both
behavioral and physiological outcome measures from differential recruitment of thermogenesis. Furthermore,
the ability to house animals at precise temperatures outside of standard housing ranges (65-75°F) permits
specific studies that rely on cold activation of adipose tissue, analyze metabolic demand without
thermogenesis for body temperature maintenance, or create perturbations that may drive, protect, or modify
pathology when modeling diseases such as Sudden Infant Death Syndrome, Malignant Hyperthermia or other
disorders. Access to housing space that provides precise adjustable control of housing temperature is needed
to facilitate these studies. The TSE-Systems Climatic Control Chambers would provide this missing component
for extended duration animal housing at precise temperatures that is critical for the success of several
metabolic, physiology, and neurologically focused research programs at Baylor College of Medicine.

Public health relevance
Project Narrative The major goal of this project is to provide access to precision-temperature-controlled environments for housing rodents undergoing studies that involve either manipulation of temperature as a component of the study or a requirement for precise maintenance of a set temperature to improve rigor and reproducibility where outcome measures are impacted by variation in ambient housing conditions.